Determining the role of lipid droplets and their therapeutic potential in glioblastoma

ABSTRACT
Over the past two decades, the prognosis for glioblastoma (GBM), the most lethal brain tumor, has remained
dismal, with a median survival of only 12-16 months from diagnosis. We recently demonstrated that GBM cells
acquire large amounts of fatty acids (FAs) and cholesterol by dramatically upregulating their de novo synthesis
and uptake for rapid tumor growth. However, excess FAs and cholesterol can alter membrane dynamics and
function, leading to cellular damage. How GBM cells avoid this lipotoxicity to sustain proper lipid levels in different
cellular compartments, particularly in the mitochondria, is poorly understood. During the past 5 years of funding,
we have made great progress in understanding how GBM controls FA homeostasis. We demonstrated that GBM
cells upregulate diacylglycerol acyltransferase 1 (DGAT1), allowing them to store abundant FAs as
triacylglycerol-containing lipid droplets (LDs) to prevent excess FA accumulation to induce toxicity. In this
renewal proposal, we will address two unanswered critical questions: 1) how is cholesterol homeostasis
regulated in GBM cells? and 2) can effective therapeutic approaches be developed for GBM by disrupting lipid
homeostasis? We recently found that cholesteryl esters (CEs), which form LDs to store excess cellular
cholesterol, are largely present in GBM tissues, and blocking CE synthesis results in dramatic mitochondrial
fragmentation in GBM cells. Moreover, our preliminary data showed that cholesterol is transferred from CE-
containing LDs (CE-LDs) to the plasma membrane, while inhibition of autophagy blocks this transfer. These data
suggest that CE-LDs maintain proper cellular cholesterol levels via autophagy. Our preliminary data further
showed that stearoyl-CoA desaturase 1 (SCD1), which has been shown to prevent endoplasmic reticulum (ER)
stress and ferroptosis, is upregulated upon DGAT1 inhibition. Finally, preliminary data showed that the
expression of multiple antioxidant genes is significantly elevated in response to DGAT1 inhibition. These results
strongly suggest that GBM cells can activate defense mechanisms to alleviate the lipotoxicity triggered by
disruption of FA storage, possibly leading to tumor resistance to DGAT1 inhibition. Thus, we hypothesize that
CE-LDs serve as critical reservoirs for controlling cholesterol homeostasis and mitochondrial function, and that
combining disruption of storage or redistribution of cholesterol with interference with mitochondrial cholesterol
import, or disruption of FA storage with either inhibition of SCD1 or blockade of antioxidant pathways are effective
strategies for targeting GBM. In Aim 1, we will examine the impact of inhibiting cholesterol storage or
redistribution from CE-LDs on cholesterol homeostasis and mitochondrial function, and whether such blockade
can synergize with interfering in cholesterol import into mitochondria to efficiently kill tumor cells in GBM
xenograft models. In Aim 2, we will examine whether inhibiting SCD1 or antioxidant pathways can strongly
synergize with DGAT1 inhibition to effectively inhibit GBM growth in vitro and in vivo. Successful completion of
this study will provide strong pre-clinical data on potential novel strategies to target GBM.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Glioblastoma (GBM) is the most common primary brain tumor in adults and one of the deadliest cancers, with a median survival of only 12-16 months from diagnosis even with extensive treatments. This application aims to elucidate the critical role of lipid storage in regulating lipid homeostasis and GBM growth, as well as to use this insight to identify and test promising combinatorial pharmacological approaches to effectively target GBM in preclinical models in order to ultimately translate them to the clinic.